Targeting Clostridioides difficile with microbiome-sparing, resistant-proof anti-toxins

Abstract: Human gut infections by Clostridioides (Clostridium) difficile (here, C.diff.) are the most lethal urgent
threat in the 2019 CDC Antibiotic Resistance Threats Report. Excess healthcare costs from these infections have
been estimated to be over $5 billion annually. Antibiotic resistance has elicited an insightful RFA RA18-725,
`Generating new insights and mechanistic understanding of antibiotic resistance'. C.diff. infections (CDI) typically
arise following treatment of other clinical disorders with antibiotics. Antibiotic therapy disrupts normal gut
microbiota, allowing C.diff. to proliferate and to repopulate the gut following treatment. Additional antibiotic therapy
to treat CDI prevents return of normal gut microbiota, leading to recurrent infections in over 20% of patients. C.diff.
has acquired resistance to several common antibiotics, compounding its therapy. Recent clinical guidelines (2018)
for C.diff. infections are oral vancomycin for patients in shock, hypotension, ileus or megacolon. Fecal transplant
is recommended for nonresponsive infections following vancomycin treatment. mAb therapies have been FDA-
approved, but are not recommended. Despite these therapies, C. difficile causes an estimated 224,000 infections
and 13,000 deaths per year (CDC in 2017). Gut epithelial cell cytotoxicity results from C.diff. production of
secreted toxins, primarily TcdA and TcdB (Tcds). Tcds are processed in gut cells to form active UDP-glucosyl
transferases that glucosylate cytoskeletal-regulating Rho, Rac and Cdc42 GTP-binding proteins on specific
threonines. Loss of cytoskeletal integrity causes severe colitis and can have a fatal outcome.
Anti-toxin immunity is a historic approach to prevent host damage from circulating bacterial toxins. We
propose that small molecule, tight-binding inhibitors targeting C.diff. Tcds can prevent the morbidity and mortality
from gut toxins in C.diff. infections. Our transition state analog approach uses kinetic isotope effects and quantum
chemistry to solve transition state structures of Tcds. Solving the first transition state structures of G-protein
glucosyltransferases, and developing the first transition state analog of any UDP-sugar transferase is innovative.
Electrostatic potential models of Tcd transition states will guide the design and synthesis of transition state
analogs. Lead transition state analog candidates will be elaborated by cycles of crystallography and chemical
design. Candidate compounds and crystal structures of Tcd complexes have been obtained in preliminary studies.
Inhibitors will be characterized against Tcds in human cells and in mouse models.
Agents to prevent tissue damage from C.diff. infections, without disruption of the gut microbiome or
pressure for microbial resistance have important medical relevance. Inhibition of Tcds in gut epithelial cells places
no selective pressure for antibiotic or anti-toxin resistance on C.diff. or on the gut microbiome, while protecting the
gut by neutralizing Tcds. Mechanistically, this approach is innovative in recapitulating vaccine-based antibody
neutralization of toxins using the powerful approach of transition state analogs.

Public health relevance
Narrative The National Institutes of Health, the World Health Organization and the Center for Disease Control are concerned that the development of antibiotics is lagging behind the rise of drug resistance and the evolution of bacterial pathogens. Knowledge of enzymatic transition states has evolved as an efficient method of drug design. This proposal applies transition state technology to the problem of antibiotic resistance and disruption of the gut microbiome in the potentially lethal colitis caused by Clostridioides difficile. The use of novel transition state analogs against the major toxins from C. difficile will protect the gut, preserve the gut microbiome and avoid the use of antibiotics that cause the development of antibiotic resistance.